Establishing a Radioanalytical Measurements Laboratory (RAM LAB) for Food Monitoring at Colorado State University

Project Summary/Abstract – Overall
The overarching aim of this project is to support food defense efforts in the State of Colorado by
establishing a radioanalytical measurements laboratory capable of monitoring human and
animal food products for radioactive contaminants. Currently none of the analytical laboratories
maintained by the State of Colorado have radioanalytical measurement capabilities that could
be utilized to perform measurements in support of food defense in either routine or emergency
situations. The Health Physics program at Colorado State University has a long-standing
tradition of carrying out radioanalytical measurements and radiochemical separations for
training and research. The initial efforts will focus on providing a laboratory capable of
monitoring food samples for gamma-emitting radionuclides in support of food defense (Track 1).
Simultaneously the capability to measure alpha-emitting radionuclides (Track 2) will be
developed by drawing on the facilities available at CSU and the expertise and the background of
the faculty in the Health Physics program.

Public health relevance
Project Narrative The overarching aim of this project is to support food defense efforts in the State of Colorado by establishing a radioanalytical measurements laboratory capable of monitoring food products for radioactive contaminants. The initial efforts will focus on providing a laboratory capable of monitoring food samples for gamma-emitting radionuclides in support of food defense. Simultaneously the capability to measure alpha-emitting radionuclides will be developed by drawing on the facilities available at CSU and the expertise and the background of the faculty in the Health Physics program.